Transcriptional Regulation of Antibody Responses and Immunity

ABSTRACT
The duration of antibody-mediated immunity varies widely with the specific immunization or infection for
reasons that remain difficult to understand or predict. The specific features of molecular circuitry in B cells and
plasma cells that are responsible for these differences have still not been defined. In this application, which
requests a second renewal of our R01 award, we seek to objectively define 1) molecular programs and cellular
trajectories that lead to long-lived plasma cells in primary responses; 2) transcriptional and epigenetic features
of memory B cells that precede durable recall responses. We will employ two BTB-POZ transcription factors
that functionally oppose each other to gain molecular footholds on programs that control plasma cell lifespan.
Modern single cell transcriptional and epigenetic programs will be employed alongside classic model antigens
and adjuvants and new genetic tools to manipulate genes in vivo. Though the experimental plan is
fundamental and basic in nature, the hope is that this work will lead to a set of rules that help predict and
optimize the duration of humoral immunity.

Public health relevance
PROJECT NARRATIVE The length of time that antibodies persist after vaccination and infection and the efficacy of these antibodies against related pathogens varies widely. The goal of this proposal is to identify genetic factors and cellular events that control the duration of immunity after vaccination.